Systems Technologies Core

The overall objective of the Systems Technologies Core (STC) is to provide expertise, state-of-the-art
instrumentation and novel analytical approaches to address a broad range of scientific questions presented
across the Center for Human Health and the Environment (CHHE) at NC State University. Expertise in
analytical evaluations is greatly needed for the translation of the CHHE’s mission to understand how human
health is impacted by environmental factors and implement this knowledge to reduce the adverse impact of
environmental factors. The STC will provide CHHE investigators with analytical expertise and state-of-art
methodologies to create an integrative, mechanistic picture of the underlying effects of environmental
exposures on human health. These methodologies include 1) genomics, transcriptomics, and epigenomics; 2)
discovery and targeted proteomics; 3) discovery and targeted metabolomics including environmental toxicants;
and 4) metallomics including metal speciation. Each section of the STC will have an expert Navigator: Dr. Erin
Baker - metabolomics/small molecules; Dr. David Baltzegar - genomics, epigenomics transcriptomics; Dr.
Michael Bereman - proteomics; and Dr. Dean Hesterberg - metallomics to provide expertise, guidance, and
consultation on experimental design for cutting-edge omics technologies. To accommodate the analytical
needs of the CHHE membership, a partnership was formed with NC State’s Measurement, Education, Training
and Research Innovation Center (METRIC) in September 2018 for proteomics, metabolomics, and metallomics
services. CHHE Full members will have priority access to these facilities and services and will be eligible to
participate in CHHE’s new STC Voucher Program which we will launch in the next funding cycle. Under this
program, CHHE will provide 50% of the costs for STC services to Full members for projects with EHS
relevance. STC is linked to NC State’s Bioinformatics Research Center (BRC) and all STC data are transferred
and stored on BRC- and CHHE-supported servers. Data can be analyzed for investigators by the STC using
dedicated software or by CHHE’s new Environmental Data Science Group within the IHSFC utilizing a
dedicated, state-of-the-art parallel computing cluster that includes high-power compute nodes, high-memory
nodes and web servers.